Multi-analyte Approach for Earlier Detection of Cancers in Non Plasma Biofluids

PROJECT SUMMARY
Early detection of cancer provides one of the most effective ways to reduce cancer related
morbidity and mortality. However, most malignancies including brain and head and neck
cancers do not have effective minimally invasive strategies for early detection. Unfortunately,
early detection is hindered by several factors, including the lack of suitable tests and cost. One
of the chief challenges in developing non-invasive tests is the identification of the appropriate
biofluid and specific markers. While blood-based testing has shown promise, many cancers are
not easily detected in the circulation. Over the past two decades, DNA released from cancer
cells has emerged as a specific biomarker of cancer. We have previously developed sensitive
methods for the simultaneous detection of multiple DNA based analytes from a small quantity of
starting material in a variety of biospecimens. We have extensive preliminary results that
biofluids, such as cerebrospinal fluid (CSF) and saliva, associated with certain cancers are
significantly enriched in released tumor DNA (rtDNA) compared to blood. In addition, our group
has an ongoing relationship with an industrial partner to translate our promising technology into
the clinical realm. This proposal will build on those strengths to develop assays for the
sensitive and specific detection of brain and head and neck cancer in CSF and saliva,
respectively. A non-plasma based “liquid biopsy” approach for the earlier detection of cancers
difficult to detect in the blood would represent a significant medical advance.

Public health relevance
PROJECT NARRATIVE We have demonstrated that biofluids in close proximity to cancers are significantly enriched for levels of released tumor DNA, which permits for greater sensitivity and potentially specificity. In this proposal we will utilize a multi-analyte approach including mutations, aneuploidy, fragmentomics and methylation to develop liquid biopsy approaches for pre-neoplastic and neoplastic conditions involving the brain and head and neck by analyzing cerebrospinal fluid and saliva respectively. We will work closely with our industrial partners, Belay Diagnostics, to validate the performance of our assays and develop CLIA certified tests ready for clinical implementation.